Integrated Electrochemical Aptamer Based Platforms for the Point-of-Care and Continuous Monitoring of Clinically Relevant Analytes

Project Summary/Abstract:
The full impact of personalized medicine can only be realized through rapid and convenient access to
individual biomarker data both at home and in the clinic. Biosensors that enable on-demand quantification of
drugs, hormones, and other clinically relevant analytes have long been promised as the next breakthrough for
facilitating precision medicine. While point-of-care and continuous glucose monitors have drastically improved
outcomes for diabetic patients, there has been virtually no clinical adoption of biosensors for other target
analytes despite tremendous potential for impact in areas such as therapeutic drug monitoring, post-operative
surveillance, and continuous hormone monitoring. Beyond enzymatic glucose sensors, electrochemical
aptamer based (EAB) sensors comprise the only other biosensing modality that has been broadly validated in
vivo. Despite demonstration of continuous sensing for over a dozen different analytes in animal models, no
EAB sensor has seen validation in human subjects due to lack of integration into deployable devices.
Therefore, a major need exists to bridge the gap between biosensor research and the type of devices needed
for real patient impact. We postulate that initial impact is particularly well-aligned with immediate needs for
high-frequency monitoring of drug and hormone concentrations in obstetric and pediatric populations, as
clinical trial data are often sparse with regard to these patients despite various physiological variations that can
lead to drastic interpatient variability in analyte concentrations.
Our central hypothesis is that through both device-oriented and novel signal-transduction innovations, EAB
sensors can achieve the performance needed to translate them from the research bench to a format that is
clinically deployable for point-of-care and/or continuous biosensing. Specifically, we postulate that
advancements in shelf storage, off-the-shelf stability, sensor interrogation, and sensor protection will allow EAB
sensors to be characterized and validated in integrated devices suitable for human subject testing.
We plan to pursue validation of our central hypothesis by (1) in vitro validating EAB sensors operating in an at-
home test strip format, (2) demonstrating the continuous operation of EAB sensors in a wearable device for >1
week and (3) validating these integrated devices in human subjects for model EAB sensors targeting the
narrow therapeutic index antibiotic vancomycin. This proposal will usher in the long-awaited validation of EAB
sensors for the on-demand monitoring of analytes in human subjects, serving as a foundation for further
clinical adoption of this sensing modality as the technology developed here is expanded to other analytes and
applications in personalized medicine.

Public health relevance
Project Narrative Obstetric and pediatric patients often suffer from imprecise medical treatment due to vast interpatient variability and lack of individualized data amongst these populations. Electrochemical aptamer based sensors offer the potential for a generalizable approach to the on-demand, high- frequency monitoring of clinically relevant analytes, which could enable personalized treatment tailored to each individual patient. This proposal will usher in the first integrated EAB platforms deployable both in the clinic and in the home of the patient, serving as a catalyst for the clinical adoption of EAB sensors for a variety of applications in the treatment of disease in children, pregnant women, and beyond.